Individualizing Steroid Use in Pneumonia (Supplement)

PROJECT SUMMARY/ABSTRACT
Pneumonia is the leading infectious cause of death worldwide. While inflammation is a hallmark pathologic
feature of pneumonia, the use of corticosteroids to blunt the profound inflammatory response remains undefined.
Decades of studies in heterogeneous populations failed to show a consistent benefit, leading to conflicting
guidelines on the use of corticosteroids. Although corticosteroids have been shown to be effective in COVID-19
pneumonia, the use of corticosteroids in other infectious pneumonia remains unclear with high variability in
clinical practice. This variability in practice presents an opportunity to see how corticosteroid administration in
pneumonia can be optimized and tailored to patient specific characteristics. The objective of this study is to adapt
advanced statistical and machine learning methods to already available robust observational data from the
electronic health record to identify predictors of clinical deterioration and to develop an individualized treatment
rule for steroid use in patients with community acquired pneumonia. This will be accomplished through three
specific aims: 1) To develop and validate a machine learning prediction tool for in-hospital disease progression,
2) To develop and test an individualized treatment rule (ITR) for steroid use, and 3) To conduct a single center
feasibility clinical trial comparing ITR and biomarker guided corticosteroid use and dosing to usual care in patients
with community acquired pneumonia. We hypothesize that: 1) a combination of demographics, physiological
parameters, clinical and laboratory data will be accurate in predicting risk of in-hospital disease progression and
identifying steroid-responsive patients in whom benefit from adjunct corticosteroid treatment outweighs potential
harm, and 2) ITR and biomarker-guided corticosteroid use, and dosing will be feasible. This career development
award will provide important preliminary data for future larger clinical trials focused on optimizing corticosteroid
use in pneumonia while training a junior investigator in the essential skills needed to become an independent
researcher.

Public health relevance
PROJECT NARRATIVE Pneumonia remains the leading infectious cause of death. Presently doctors do not know which patients can benefit from steroids, when to give steroids, or how much steroid to give. In this application, we propose an approach to steroid use in pneumonia that considers an individual’s unique features, seeking to give the right dose of steroid to the right patient and at the right time.